Calcium Signaling in Hematopoiesis

Project Summary
Current understanding of the molecular mechanisms underlying hematopoietic stem cell specification (HSCs) to
generate induced pluripotent stem cells (iPS cells) is still limited. In this proposal, we seek to understand the role
of calcium signaling, acting through CaMKII, in HSC specification in zebrafish embryos. Suppression of one of
the seven transcriptionally active CaMKII genes, camk2g1, leads to increased expression of ezh2, the functional
enzymatic component of the polycomb repressive complex 2 (PRC2), inhibiting HSC specification. We first seek
to characterize the role of camk2g1 in HSC specification through use of genetic knockdown techniques and
pharmacological inhibitors. We then seek to determine how increased expression of ezh2 in camk2g1 deficient
embryos alters downstream signaling important for HSC specification. Preliminary results suggest increased
ezh2 expression inhibits downstream expression of target genes (tgfbr2 and jag1a) resulting in apoptosis of
HSCs in the ventral wall of the dorsal aorta. The results from this proposal will provide novel insight into the
calcium-dependent signaling pathways necessary to generate all lineages of HSCs from iPS cells.

Public health relevance
Project Narrative Hematopoietic stem cells (HSCs) are a self-renewing population of precursors that can proliferate and differentiate into all blood and immune cells over the lifetime of an individual, and comprise the therapeutic component of bone marrow transplants. Recent technological advances have raised the possibility of generating HSCs from induced pluripotent stem cells (iPS cells), however the inability to generate all blood cell lineages from iPS cells demonstrates an incomplete understanding of the signaling required to properly specify HSCs. This proposal demonstrates that calcium signaling, acting through CaMKII, regulates epigenetic mechanisms to specify HSCs and provides additional insight into the pathways required to generate HSCs from iPS cells.